Core C: Biospecimen, Pathology, and Genomics Core

PROJECT SUMMARY/ABSTRACT
The Biospecimen, Pathology and Genomics (BPG) Core for the Yale Lung Cancer SPORE will serve as the
facility for all human biospecimen acquisition, processing and analysis for all SPORE-sponsored research. We
will continue to manage, bank and distribute lung cancers obtained from all interventionalists and surgeons as
this occurs at the bedside or in the operating room with research tissues derived from extra passes of the
biopsy needle after the diagnostic specimen has been collected. Furthermore, the Biospecimen, Pathology
and Genomics Core will work closely with Yale Pathology Tissue Services, the research tissue procurement
service supported within the Department of Pathology (also directed by David Rimm) to facilitate safe and rapid
acquisition of all fresh lung cancer resection specimens. The Biospecimen, Pathology and Genomics Core
presents the following specific aims to achieve the goals and mission of the Core in service to the Yale SPORE
in Lung Cancer:
Specific Aim 1. To collect, store and distribute human biospecimens with complete clinical, pathological, and
demographic annotation for use in Projects 1-3, Developmental Projects and Career Enhancement Awards.
Specific Aim 2. To conduct or assist in molecular pathology analyses of biospecimens including nine modalities
for analysis of tyrosine kinase signaling pathways, immune microenvironment, immune profiling and immune
monitoring.

Public health relevance
NARRATIVE The Biospecimen, Pathology and Genomics Core (Core C) is a required component of all SPORE applications. Core C will serve as a comprehensive biorepository and distribution mechanism for all lung cancer cases at Yale. Core C will also assist and facilitate conventional and cutting edge tissue analysis needs for all of the SPORE projects.